Interplay between hypoxia and oxidative phosphorylation in herpes stromal keratitis

Herpes stromal keratitis (HSK), a corneal chronic inflammatory condition that develops in response to recurrent
corneal herpes simplex virus-1 infection, can cause permanent scarring and vision loss. Chronic inflammation
often makes tissue hypoxic due to the lack of the blood vessel, reduced supply of blood, and a high metabolic
demand of infiltrating immune cells. Development of hypoxia leads to the stabilization of hypoxia inducible factor
(HIF), a transcription factor, which enhances the expression of glycolysis regulating genes and thereby promotes
glycolytic metabolism. However, blocking of HIF signaling may promote oxidative phosphorylation to sustain the
energy demand of inflammatory cells in inflamed tissue, suggesting an interplay between hypoxia and oxidative
phosphorylation to prevent the resolution of an ongoing inflammation. Our preliminary results showed the
development of hypoxia in corneas with HSK. Furthermore, the development of hypoxia was linked with the
extent of neutrophils in HSV-1 infected corneas. When hypoxia associated signaling pathway PCR array and
RT-qPCR were carried out on progressing HSK lesions, we detected an elevated expression of genes encoding
key glycolytic enzymes, including PFKFB3 in infected corneas. PFKFB3 is a glycolytic activator, which is reported
to enhance hemangiogenesis. We also found an increased level of expression of lactate transporters, MCT4 and
MCT1, in corneas with HSK. RT-qPCR results were confirmed with confocal microscopy and flow cytometry. Our
results also showed the nuclear localization of HIF-2 in epithelial cells, and HIF-1 in infiltrating neutrophils and
CD4 T cells in HSK corneas. Interestingly, blocking of HIF dimerization, while using acriflavine, in HSV-1 infected
mice exacerbated the corneal opacity, but decreased the hemangiogenesis. Our preliminary results and
supportive published evidence together led us to hypothesize that neutrophils in HSK lesion shape the
development of hypoxia resulting in the prevalence of HIF-regulated glycolytic metabolism that promotes HSK
pathogenesis, and blockers of HIF, when given in association with inhibitors of mitochondrial respiration or
reactive oxygen species (ROS) should reduce the severity of HSK. Three aims are proposed to test this
hypothesis. Aim 1 will test the hypothesis that neutrophils in HSK lesion shape the development of hypoxia, and
hypoxia enhances the severity of HSK. Aim 2 will test the hypothesis that inhibition of glycolytic activator
PFKFB3, and the lactate transporter MCT4 and MCT1 protein reduces the severity of HSK. Aim 3 will test the
hypothesis that blockers of HIF in association with an inhibitor of mitochondrial respiration or ROS will reduce
the severity of HSK. Given the results from these studies, novel therapeutic approaches for treating HSK lesions
may be developed. The knowledge gained from this application will provide innovative information that could be
applicable to other ocular infection disease models.

Public health relevance
Herpes stromal keratitis (HSK), a corneal chronic inflammatory condition that develops due to herpes simplex virus-1 infection, can cause the loss of vision. In this study, we will carry out novel approaches to manage HSK by understanding the development of hypoxia, and the role of hypoxia regulated genes in corneas with HSK.